Training Core

The goal of the Harvard Kidney, Urology and Hematology Training Institute’s (HKUHTI) Training Program is to
educate the next generation of diverse leaders of KUH research by leveraging the intellectual, collaborative, and
physical resources of our rich Boston ecosystem. Five partnering institutions request support for a TL1
Training Core to fund 10 pre- and 24 postdoctoral trainees in the steady state of the grant (after some
adjustments in the first year taking into account the end of existing T32 grants). Trainees will benefit from
HKUHTI-specific, as well as Harvard-wide, collaborative training curricular offerings that will be tailored to the
trainee’s individual scientific and career goals. The TL1 will be led by Dr. Anna Greka, who is part of the
leadership for the Biological and Biomedical Sciences (BBS) Graduate Program at HMS and the Leadership
Council of the Harvard-MIT MD-PhD Program. The HKUHTI will employ a rigorous selection process that will
result in a highly diverse group of trainees from across the country into a program that provides rigorous training
with a world-class roster of mentors in KUH fields. Trainees will benefit from a primary mentor, and an individual
oversight committee (IOC) throughout their tenure in the program. The HKUHTI will expose trainees to a range
of innovative research opportunities including those offered by established mentors at the Broad and Wyss
Institutes, MIT and others, and will leverage the clinical and translational research accelerator, the Harvard
Catalyst. The TL1 will address many identified challenges to training the next generation of KUH research leaders
and will build on a strong history of success in producing and retaining leaders in KUH biomedical sciences.
The requested positions will bring together K, U, and H across pediatric and adult divisions. The TL1 is closely
linked to the U2C, incorporating rich Professional Development and Network Cores, and the supported trainees
will benefit from a robust Administrative Core with a digital Hub, oversight committees and evaluation
infrastructure. Formalized structures are established for recruitment, selection, and retention, as well as
mentor and trainee selection and evaluation. Special attention will be devoted to enabling trainees to
overcome experimental and personal hurdles in their training. The TL1 will focus on offering trainees the
knowledge needed to perform state-of-the-art science and prepare for a productive and rewarding career
in KUH fields. Additionally, the TL1 is structured to provide oversight to trainees and ensure that trainee,
mentor(s) and IOC co-develop an Individualized Training Plan in a cooperative manner, such that the needs,
emerging research interests and future career of the trainee are always at the center of their training experience.
The structure of the TL1 program was intentionally designed to address seven major challenges identified by
surveying the trainees (see Training Plan). In addition, the HKUTHI will benefit from validated evaluation tools to
collect data and address emerging trends and scientific challenges to ensure that trainees, mentors and the
entire HKUHTI community achieve measurable personal, professional and scientific growth.
Project Summary/Abstract

Public health relevance
No PHR